Stressors and Health Disparities Research Program

One of the goals of the 'Stressors and Health Disparities' laboratory is to examine psychosocial stressors and cardiovascular health. The following manuscripts specifically explore this goal.

The following 4 manuscripts were developed by the staff of the Stressors and Health Disparities laboratory:
#1: Barlow et al prospectively examined whether perceived skin tone discrimination (in-group and out-group) discrimination was associated with incident cardiovascular disease (CVD) and whether these associations varied by sex and optimism among 3519 adults in the Jackson Heart Study. Findings suggested that skin tone discrimination may be a unique risk factor for CVD.

#2: Forde’s editorial on the manuscript on racial and/or ethnic variation in referral to outpatient heart failure by Wang et al. provided a description of the objectives, methods, results, limitations and strengths of the study. Forde concluded that the article by Wang et al. addressed important knowledge gaps regarding racial and/or ethnic disparities in outpatient heart failure management referral patterns and highlighted the importance of optimizing the health care of patients with heart failure.

#3: Dhingra et al conducted a systematic review of 10 studies that examined the relationship between stressors and cardiometabolic outcomes during pregnancy. The review suggested that experiencing specific stressors were associated with cardiometabolic outcomes during pregnancy and future research could focus on additional stressors.

#4: Cho et al. analyzed quantitative and qualitative data from a nationally representative survey of 5480 American Indian/Alaska Native, Asian, Black/African American, Hispanic/Latino, Multiracial, Native Hawaiian/Pacific Islander and White adults across the United States to examine whether the prevalence of perceiving direct interpersonal and vicarious experiences of unfair treatment varied across racial and/or ethnic groups. The study findings suggested that perceived direct and vicarious experiences of unfair treatment were more prevalent among specific racial and/or ethnic groups and varied across domains of type of mistreatment and settings where unfair treatment occurred.

The following manuscript was developed by collaborators of the Stressors and Health Disparities laboratory:

#5: Wilkerson et al. used data from a nationally representative survey of 5500 American Indian/Alaska Native, Asian, Black/African American, Hispanic/Latino, Multiracial, Native Hawaiian/Pacific Islander and White adults in the United States to examine the impact of perceived unfair treatment on healthcare access. The authors reported that perceived unfair treatment was associated with increased likelihood of being unable to obtain healthcare for all racial and/or ethnic populations, but was strongest for certain populations.